Student Urinary Tract Program in Education and Research (SUPER) Summer Training Program

ABSTRACT
There are an estimated 50 million Americans with chronic kidney disease (CKD), and the care provided to
people with CKD and end stage kidney disease exceeds $114 billion annually. Despite these numbers, recent
data indicates that there is a significant workforce shortage in the field of nephrology and urology and the total
number of grants submitted to the NIH focused on kidney and urologic diseases and disorders has decreased
over the past decade. This dichotomy creates a significant need to reverse the current trends and increase the
number of trainees interested in pursuing a career in nephrology and urology that includes an NIDDK-related
research focus. To begin to address these important issues, we propose to create a predoctoral student
research program that combines the educational, clinical, and translational research expertise at The Ohio
State University and Nationwide Children’s Hospital. The long-term goal of this program is to increase and
diversify the number of physician-scientists and basic-scientists submitting grant applications to the NIDDK in
the fields of pediatric nephrology and urology. To accomplish this goal, we propose the development of a new
Student Urinary Tract Program in Education and Research (SUPER) Summer Training Program for graduate
and medical students. This program will expand established research programs and partner with local
resources to create new educational and research experiences promoting the understanding of kidney and
urinary tract diseases. We strongly believe that creating this innovative and well-structured summer research
program focused on nephrology and urology related topics will capture predoctoral student interest early in
their career development - thereby increasing the potential workforce population and creating the next
generation of NIDDK-research focused clinicians and scientists.

Public health relevance
PROJECT NARRATIVE This proposal seeks to provide a transformative 12-week summer research program for medical and graduate students that will encourage them to pursue careers in kidney and urinary tract related research and clinical programs. This program is also designed to attract minorities and students from underserved and disadvantaged communities with the long-term goal of increasing and diversifying the number of physician-scientists and basic- scientists submitting grant applications to the NIDDK in the fields of nephrology and urology.